Animal Imaging

ABSTRACT
The Animal Imaging Core’s provides investigators with unique, state-of-the-art capabilities for non-invasively
detecting, localizing, and biologically characterizing primary and metastatic cancer cells in vivo in small-animal
(i.e., rodent) models. The core's major goals are: 1) to provide a large number and variety of non-invasive,
quantitative small-animal imaging modalities: magnetic resonance imaging and spectroscopic imaging (MRI
and MRSI, respectively), positron emission tomography (PET) and single-photon emission computed
tomography (SPECT) of radiolabeled tracers, computed tomography (CT), optical imaging of luminescent and
fluorescent probes, and structural and functional ultrasound scanning as well as therapeutic irradiation; 2) to
provide analytics support as needed (data processing and management, image reconstruction, etc.); and 3) to
provide consultation for experimental design and training in the use of the Core’s instrumentation.